Hemodynamics of thrombosis after transcatheter aortic valve-in-valve implantation

ABSTRACT I
This is an application for a Mentored Quantitative Research Development Award for Dr. Yue Xuan, a
biomedical research scientist at the University of California, San Francisco. Dr. Xuan is establishing herself as a
young investigator in patient-oriented research of aortic valve replacement. This K25 award will provide Dr. Xuan
with the support necessary to accomplish the following goals: (1) to focus on clinical investigation of the
thrombosis after transcatheter valve-in-valve implantation; (2) to acquire training in radiology and identify the risk
factors of thrombosis by incorporating the clinical data and patient-specific computational modeling; and to (3)
integrate her biomechanical expertise to answer clinical questions in the treatment of cardiovascular diseases.
While Dr. Xuan has a solid background in computational modeling, she is much less so in the other important
disciplines named above. To achieve these goals, Dr. Xuan has assembled a mentoring team comprised of a
primary mentor, Dr. Elaine Tseng, Professor of Surgery at UCSF and Chief of Cardiothoracic Surgery in San
Francisco Veterans Affairs Medical Center, co-mentor, Dr. Liang Ge, an Assistant Adjunct professor in UCSF,
who has expertise in computational modeling of ascending aortic aneurysm and aortic valve disease, and co-
mentor Dr. Danny Dvir, international leader in valve-in-valve therapies and valve degeneration and an
interventional cardiologist in University of Washington. Dr. Xuan will also work closely with Dr. Kendrick Shunk
and Jeffery Zimmet, interventional cardiologist in UCSF and San Francisco VA Medical Center, to understand
the clinical questions of the valve-in-valve procedure. The mentoring team also includes Dr. Michael Hope,
associate professor in UCSF and Chief of radiology in San Francisco VA Medical Center and Dr. David Saloner,
professor in Radiology at UCSF and international leader in cardiovascular MRI, who will supervise and direct the
medical imaging and MRI study. Dr. Xuan has developed structured training plan incorporating of didactic
training, formal coursework, besides multidisciplinary mentorship in clinical study, medical imaging and patient-
specific computational modeling.
Transcatheter aortic valve-in-valve (VIV) implantation stands to revolutionize the treatment of aortic valve
disease after a failed surgical bioprosthetic valve. The proposed study will incorporate both the clinical imaging,
clinical follow-up data and patient-specific computational simulation to address the most urgent questions for the
thrombosis after VIV. We expect the outcomes of these studies will fill critical knowledge gaps in thrombosis
formation from the hemodynamics perspective, improve clinical management of thrombosis, and significantly
improve the future clinical outcome through patient-specific risk prediction. This research will form the basis for
an in-depth study of thrombosis and bioprosthetic valve failure in the VIV procedure, to be proposed in an R01
grant application before the end of the proposed project.

Public health relevance
PROJECT NARRATIVE I There is urgent need to understand the mechanism of thrombosis formation after transcatheter aortic valve-in- valve implantation (VIV) as implanted surgical bioprosthetic valves are deemed to fail due to structural valve degeneration. A clinical follow-up investigating the thrombosis after VIV combined with patient-specific computational modeling will provide critical knowledge to understand the biomechanical risk factors for thrombosis in a timely manner.